Mechanisms and Regulations of Neutral Lipid Metabolism

PROJECT SUMMARY/ABSTRACT
The biosynthesis of neutral lipids including triacylglycerols (TG) and sterol esters (SE) is a ubiquitous mechanism
for storing metabolic energy and lipid substrates (e.g., fatty acids) in eukaryotes. However, excessive neutral
lipid production leads to obesity in humans, which in turn contributes to the pathogenesis of metabolic syndrome
and various types of cancer. Given the physiological role of this lipid anabolic pathway in directing metabolic
energy and lipid metabolites from utilization (e.g., membrane synthesis) into storage, it must be precisely
regulated. Our research program will discover and elucidate the underlying regulation mechanisms at the
mechanistic level. To generate neutral lipids, two homologous integral membrane acyltransferases, DGAT1 and
ACAT1, catalyze the terminal and rate-limiting steps in TG and SE production, respectively. Interestingly, due to
the insoluble nature of TG/SE, both enzymes adopt an unusual multi-pass transmembrane topology to mediate
TG/SE biosynthesis in the plane of the membrane at the endoplasmic reticulum (ER). This unique mode of
membrane-embedded catalysis is crucial for spatially confining TG/SE formation within a stringent hydrophobic
environment, thereby preventing their exposure to the cytoplasmic aqueous phase. To ensure overall cellular
lipid homeostasis, our central hypothesis is that the enzymatic activities of DGAT1 and ACAT1 undergo rigorous
regulations. Our preliminary data indicate that the intrinsically disordered segment at the cytoplasmic N-terminal
region of DGAT1 effectively suppresses its activity in vivo. While this observation suggests an auto-inhibitory
regulation, our studies also reveal that DGAT1 undergoes substantial activation through interactions with specific
lipid ligands. Based on the available evidence on ACAT1 biochemical features and its high degree of structural
homology with DGAT1, we hypothesize that both enzymes undergo significant activation/inhibition regulations
through similar mechanisms. However, the molecular basis underpinning these regulations uniquely occurring
in the lipid bilayer remain largely unknown. Using a combination of structural biology, lipid biochemistry, and cell
biology approaches, we will elucidate how these regulations are implemented at the molecular and cellular level.
In addition, DGAT1 and ACAT1 are members of a large enzyme family known as membrane-bound
acyltransferase (MBOATs). This class of enzymes have emerged as critical therapeutic targets demonstrated by
their promise in treating lipid associated disorders and certain types of cancer using pharmacological inhibitors.
However, the mechanisms of MBOAT inhibitors remain poorly defined. Building on our recent elucidation of the
DGAT1 inhibition mechanism, our research program will also unravel the molecular principles governing the
actions of MBOAT inhibitors. We anticipate that the insights gained from our program will establish a new
conceptual framework to greatly advance our understanding of lipid metabolism and potentially inspire novel
therapeutic strategies for treating lipid-associated disorders to improve human health.

Public health relevance
PROJECT NARRATIVE Disruption of lipid homeostasis leads to numerous diseases, including obesity, metabolic syndrome, and cancer, posing serious health threats and substantial economic burdens. This proposal aims to elucidate the regulation mechanisms governing lipid storage and to identify the molecular principles for developing novel, potent and safe drugs targeting the lipid metabolism pathway. The results will not only uncover fundamental aspects of lipid metabolism but may also offer novel therapeutic strategies to improve human health.